Structural Core

Core C: EM and Mass Photometry Structural Core
Project Summary Abstract
This is a renewal application of a long-standing P01 grant. Core C provides support for structural studies
including routine and advanced transmission electron microscopy, cryo-EM, cryo-shadowing (a technology not
available anywhere else) and the novel transformative technology of Mass Photometry. Members of the program
project have direct access to this support through routine day to day analysis of samples and also in-depth
research projects carried out between members of the core and members of the program project groups. The
expertise of the Griffith laboratory in herpesvirus studies augments core C studies.

Public health relevance
Core C: EM and Mass Photometry Structural Core Project Narrative Core C, Electron Microscopy and Mass Photometry provides support for all projects in the area of structural biology including EM, cryoEM, Mass Photometry and immuno-EM. Both routine analysis and long-range in- depth studies are conducted with members of the program project.